Remote Kinesiology for Improving Human Health with Auto-locating Compliant Motion Tracking Stickers and Artificial Intelligence

PROJECT SUMMARY/ABSTRACT
Body mounted inertial measurement units (IMUs) enable human motion tracking and kinematic analysis
beyond the traditional healthcare setting of a hospital or lab. This is a powerful platform for studying how
physical conditions and diseases affect the kinematics of daily activities. Clinical adoption of these body
mounted IMUs can lead to new treatment methods and more efficient utilization of healthcare resources [1]–
[3]. Bulky and uncomfortable form factors of body mounted IMUs, however, compromise patient adherence
and limit clinical adoption [4], [5]. Furthermore, the inability of body mounted IMUs to be removed/replaced on
the body without corrupting most kinematic models and activity classification algorithms, creates the possibility
of significant error during unsupervised use or extended durations of wear [3]. Such challenges with wearability
and usability interfere with the ability to fully realize the potential of body mounted IMU motion systems for
clinical applications. In an effort to address this need, I will apply and evaluate the rapid fabrication techniques,
developed by my lab, to manufacture a fully flexible, extensible, and soft IMU sticker [6]. I will also investigate
the use of artificial intelligence/machine learning to detect the anatomical placement location of body mounted
IMUs through common physical therapy exercises. To accomplish this, I will leverage the natural kinematic
constraints of the body such as axes of rotation, range of motion, and angular velocity, which are unique to
specific regions of the body, to classify the IMU locations with supervised learning [7]. I have already
manufactured a network of unobtrusive body mounted IMUs stickers and developed an approach of using
globally referenced quaternions to track, visualize, and analyze human motion in real-time. I have empirically
determined that the accuracy of this system is comparable to other IMU-based motion tracking systems, and I
have already begun collecting motion tracking data of common physical therapy exercises. I hypothesize that a
more compliant IMU sticker developed using rapid fabrication methods and a K-nearest neighbor (KNN)
classifier trained with motion tracking data (unaltered or decomposed using Principal Component Analysis
(PCA)) will detect the anatomical location of randomly placed body mounted IMU stickers through common
physical therapy exercises. The result of this work will allow me to improve the health outcomes of people in
the future through kinematics, IMUs, and AI.

Public health relevance
PROJECT NARRATIVE Clinical use of body mounted motion tracking systems containing inertial measurement units (IMUs) can provide insight into new rehabilitative treatment, however, bulky hardware impedes natural motion and current IMU-based systems rely on precise body placement. The proposed research will investigate rapid fabrication techniques to achieve thin, flexible, extensible form factors, and machine learning algorithms to detect the anatomical location of body mounted IMUs through common exercises. Such work will build on my preliminary efforts in creating networks of body mounted IMU stickers that track the kinematics of human motion for improving human health.